Role of SHARPIN in the Adhesive and Inflammatory Functions of Platelets and Endothelial Cells

PROJECT SUMMARY
Integrin αIIbβ3 (GP IIb-IIIa) is the platelet receptor for fibrinogen and is required for platelet aggregation during
hemostasis. Fibrinogen binding to platelets is regulated by interactions of specific intracellular proteins, including
talin and kindlin-3, with the β3 cytoplasmic tail. In contrast, proteins that might interact with the αIIb tail to regulate
fibrinogen binding are relatively unexplored. We have found that human and mouse platelets and endothelial
cells express the 40 kDa protein, SHARPIN. Studies with human platelets as well as with platelets and
megakaryocytes derived from human induced pluripotent stem cells have revealed that SHARPIN can interact
directly with either the αIIb tail or with two other proteins to constitute the linear ubiquitination chain assembly
complex (LUBAC). In fact, stimulation of platelets by traditional hemostatic agonists, such as thrombin, or by
inflammatory agonists, such as lipopolysaccharide or soluble CD40 ligand (sCD40L), triggers both fibrinogen
binding to αIIbβ3 and Met1-linked linear ubiquitination of IKKγ (NEMO) to promote NF-kB pathway signaling.
SHARPIN knockdown by shRNA in megakaryocytes and platelets results in decreased agonist-induced, linear
ubiquitination of NEMO, but increased fibrinogen binding to αIIbβ3, MHC Class I expression, and release of
endogenous sCD40L. Here we will test the hypothesis that SHARPIN’s mutually exclusive interactions with
integrin α tails or LUBAC regulate critical platelet and/or endothelial cell responses during hemostasis,
thrombosis, inflammation and angiogenesis. Aim 1 will use advanced techniques, including optogenetics, to
determine the stoichiometry of SHARPIN and αIIbβ3 in platelets and to test the functional effects of enforcing
SHARPIN interactions with either αIIb or LUBAC. Platelet-specific SHARPIN knockout mice will be generated in
order to test the requirement for platelet SHARPIN in hemostasis, thrombosis and inflammation using a range of
mouse models. Aim 2 will determine the role of SHARPIN in the adhesive and angiogenic functions of integrin
αVβ3 and in NF-kB pathway signaling in endothelial cells. Endothelial cell SHARPIN will be specifically and
conditionally knocked out in mice, and lung microvascular endothelial cells from these mice will be evaluated for
αVβ3-dependent adhesive responses and for angiogenic sprouting. The effects of deleting endothelial cell
SHARPIN in vivo will be determined using established mouse models of developmental and pathological
angiogenesis. This project will make heavy use of the Hemostasis, Thrombosis, and Inflammation Models Core
and it will collaborate with all other projects in this Program to achieve its aims. Altogether, these studies will
provide a comprehensive test of the central hypothesis and establish new mechanistic insights into the regulation
of integrin and immune signaling by SHARPIN in vascular cells, with clear implications for hemostasis,
thrombosis, inflammation and angiogenesis.